Glycolytic metabolites, Calcium entry and Sjogren’s syndrome

Project Summary
Saliva is essential for maintaining oral health and it has been estimated that more than 5 million people in
the US suffers from salivary gland dysfunctions. Primary Sjögren's syndrome (pSS) is an autoimmune
disease with unknown etiology and multiple factors have been suggested to play a role in the pathogenesis
of pSS. Importantly, infiltrating immune cells (especially Th17 cells), autoantibodies producing B cells, and
dendritic cells are shown to be highly present in salivary glands of pSS patients; however, the mechanism
as why these immune cells are present in salivary tissues is not known. Although Ca2+ is shown to play a
central role in regulating saliva secretion as well as in immune cell activation, information regarding the
mechanism that modulate Ca2+ channel activity in pSS is not well understood. Endogenous metabolite,
such as lactate was previously considered as a waste product of cellular metabolism, but recently it has
been shown that these metabolites effectively modulate the immune response. L-lactate inhibit T cell
motility thereby preventing the movement of T cells, back from the inflamed tissues and increase in lactate
levels are observed in the salivary glands of pSS mouse models and in pSS patients. Importantly, increase
in lactate levels were critical in inhibiting STIM1 migration thereby preventing Ca2+ entry in salivary gland
cells that lead to a decrease in ER Ca2+ levels and induced ER stress. Lactate-mediated induction of ER
stress releases alarmins that is essential for T/B cell activation and their migration into salivary tissues.
Finally, lactate-mediated loss of Orai1 activity resulted in the overproduction of IFN and IL-17 cytokines
from CD4+ T cells and inhibited mitochondrial function that was important for metabolic reprograming
needed for T cell switching. The objective of this grant is to elucidate the mechanism(s) thereby
endogenous metabolites, such as lactate modulates Ca2+ signaling and leads to salivary gland dysfunction.
This application is based on the hypothesis that lactate induces autoimmunity by inhibiting Ca2+ entry
channels which results in decreased saliva secretion and suppression of the oxidative phosphorylation.
The results of our studies are expected to provide new insights into the role of endogenous metabolites in
regulating Ca2+ channels and the molecular mechanism involved in salivary gland dysfunction as well as
establish ways to restore functional salivary glands. Greater understanding of these events will be
important in elucidating new therapy for salivary gland dysfunctions.

Public health relevance
Project Narrative Our studies are focused on characterizing the role of endogenous metabolites in inhibiting saliva secretion that leads to salivary gland dysfunctions. Elucidating the mechanism of lactate mediated inhibition of saliva secretion and immune cell activation; is important in elucidating new therapies for salivary gland dysfunctions.